Administrative Core

Administrative Core
The Administrative Core includes the four PIs, Drs. Ahles and Gany (MSK) and Drs. Hubbard and Vuong
(CCNY), Research Education Core Leaders Dr. Hricak (MSK), with Drs. Hubbard and Vuong; Partnership
Community Outreach, Research, and Education/Engagement Core (PCORE) Leaders Dr. Leng (MSK), and Dr.
Lubetkin (CCNY); Linguistic and Cultural Responsiveness Shared Resource Core (LCRSRC) Leaders Drs.
Gany and Diamond (MSK) and Drs. Riobó, Uyar, and Wei (CCNY), and the Administrative Core staff, from both
CCNY and MSKCC. The U54 Administrative Core coordinates all of the Partnership activities and ensures that
the Partnership continues to function effectively and efficiently. Specifically, the Administrative Core will: 1)
coordinate biweekly meetings of Partnership PIs; quarterly meetings of the Administrative Committee (which
includes the leaders of the Research Education Core, PCORE, LCRSRC, and Working Groups); quarterly IAC
meetings; the Annual Program Steering Committee meeting, and any ad hoc meetings; 2) meet with the
Executive Committee on an annual basis to evaluate the potential synergy between Partnership goals and new
institutional initiatives, including recruitment of new faculty; 3) provide support for both institutions' research
resources and facilities and to provide access to and awareness of these resources for Partnership
investigators, faculty, and students; 4) support the Research Education Core with student placements at either
CCNY or MSK in research laboratories or service-based learning projects and to provide administrative support
for faculty that teach in Partnership courses; 5) in collaboration with the Planning and Evaluation Core, to ensure
ongoing planning, monitoring, evaluation and tracking of Partnership activities, including fiscal planning and
management for all aspects of the Partnership and the distribution of developmental funds; and 6) maintain and
update a manual of Standard Operating Procedures.

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete